Rapid 3D Bioprinting of Cell-Laden Neurotrophic Factory Gradient Conduit for Neural Tissue Regeneration and Functional Recovery

PROJECT SUMMARY
There is a clinical need for an effective neural guidance conduit to treat long gap peripheral nerve injuries. Many
studies have explored different materials and active cues to guide neural regeneration, with some success.
However, none have demonstrated a comparable or better functional recovery than the gold standard autograft.
An autograft requires an additional surgery to remove a sensory nerve such as the sural nerve from the patient
which can lead to loss of sensation. Additionally, an autograft is not a sufficient treatment to restore function for
large gap injuries to the brachial plexus and sciatic nerves. We hypothesize that a synergistic combination of
physical, cellular, and biochemical guidance cues is required to achieve robust functional recover on
par or better than that provided by an autograft. A 3D printed conduit can be designed to match the size of
the injury defect for patient specific care. Rapid Projection, Image-guided, Direct Printing (RaPID) is capable of
producing true-3D cell-laden hydrogel constructs with microscale features on the order of seconds to minutes.
Schwann cells play a key role in endogenous peripheral nerve regeneration by releasing neurotrophic factors to
both sustain and guide the regenerating axons. GDNF is a neurotrophic factor of high interest for its role in motor
neuron regeneration. The authors plan to address the hypothesis by first genetically engineering Schwann cells
to overexpress GDNF, then anchoring them via photochemistry along the length of the 3D-printed multi-
microchannel conduit in a density gradient pattern to create a persistently generated soluble GDNF gradient.
Once validated, the authors plan to run an in vivo study in a murine sciatic nerve injury model to access the
functional recovery efficacy of the synergistic conduit versus the acellular conduit and autograft. This proposal
addresses the NINDS mission of reducing the burden of neurological disease for every age group and segment
of society by developing a tailored-to-patient conduit with synergistic cues for enhanced restoration of function
after a PNI.

Public health relevance
PROJECT NARRATIVE There is a critical need for a neural conduit to effectively treat long gap peripheral nerve injuries. Our preliminary work demonstrates that an acellular multi-microchannel conduit alone provides some functional recovery post- injury, but not to the degree of an autograft. By incorporating both cellular and biochemical guidance cues to the conduit’s mechanophysical cues, we expect to synergistically achieve robust functional recovery at least to the level of the gold standard autograft, which would be highly desirable for therapeutic PNI clinical translation.